Project 2: Dual Targeting of B7-H3 in mCRPC

PROJECT 2 – PROJECT SUMMARY
Immune-checkpoint blockade has resulted in unprecedented treatment advances in multiple tumor types, despite
yielding modest results in prostate cancer (PCa). While CTLA-4 and PD-L1 are infrequently expressed in PCa,
B7-H3 (another B7 superfamily member) is highly expressed in many PCas, modulates anti-tumor immune
responses, and is associated with worse prognosis. Targeting B7-H3 is now clinically feasible with the
development of Enoblituzumab, an investigational humanized Fc-optimized (for antibody-dependent cellular
cytotoxicity [ADCC]) monoclonal antibody that binds B7-H3 with high affinity, and with MGC018, a
duocarmycincontaining humanized antibody-drug conjugate (ADC) that also binds non-competitively to B7-H3
with high affinity. Notably, enoblituzumab and MGC018 bind to different epitopes on B7-H3, permitting rational
combination of these two agents. Here, we propose to test the hypothesis that B7-H3–targeted treatment (using
the ADC with or without the monoclonal antibody) in patients with metastatic castrate resistant prostate cancer
will be safe, tolerable and lead to PSA and radiographic responses, by modulating T cell immunity in the tumor
microenvironment (TME) as well as direct tumor killing by duocarmycin ± ADCC-directed activity. We will build
on our prior experience from our recently completed investigator initiated Enoblituzumab monotherapy trial
(n=32, NCT02923180) to test the hypothesis that therapeutic efficacy can be enhanced through a combination
of enoblituzumab’s myeloid-enhancing and T cell-enhancing activity plus direct B7-H3–targeted cytotoxicity with
MGC018’s duocarmycin payload. Our specific aims are: (1) To investigate the safety and clinical efficacy of
B7H3–targeted treatment (MGC018 alone or combined with enoblituzumab) in the mCRPC setting, (2) To assess
the pathologic and adaptive immunologic effects of single (MGC018) or dual (MGC018 plus enoblituzumab)
B7H3 targeting in PCa, and (3) To interrogate functional antigen-specific T cell repertoires induced by single or
dual targeting of B7-H3 in PCa. These studies will provide the first in-human assessment of immunotherapy-
mediated gene expression changes, both peripheral and intratumoral, in relation to targeted treatment against
B7-H3 mediated by cytotoxic (MGC018) +/- ADCC activity (enoblituzumab) to determine if synergistic anti-tumor
activity is observed. These studies will be the first to integrate novel spatial proteomic/transcriptomic, T cell
repertoires, and functional analyses in PCa patients thereby potentially identifying critical immune molecules and
pathways that can be targeted for additional combinatorial immunotherapy PCa trials in the future.

Public health relevance
PROJECT 2 - PROJECT NARRATIVE Immunotherapy–the use of a person’s own immune system—to target and kill melanoma, lung, and colon cancer has resulted in unprecedented advances in treatment. However, in PCa immune-checkpoint blockade utilizing anti-CTLA-4 or anti-PD1 antibodies has yielded minimal clinical activity to date, as these pathways may not be primary checkpoints in PCa. In the described clinical trial herein we are investigating the anti-tumor, immunological and biological effects of B7-H3 +/- ADC chemotherapy in men with metastatic castrate resistant prostate cancer utilizing Enoblituzumab (a humanized monoclonal antibody against B7-H3) and MGC018 (a duocarmycin-containing humanized antibody-drug conjugate (ADC) that also binds non-competitively to B7-H3).